The Roadmap from Preclinical Models to Interventional Trials for PTE

Summary/Abstract
The Roadmap from Preclinical Models to Interventional Trials for Post-Traumatic Epilepsy (PTE) Conference will unite global leading clinical and preclinical experts in traumatic brain Injury (TBI) and epilepsy to focus on PTE, promoting crosstalk with the goal of delivering an actionable plan for the preclinical to clinical application of biomarker discovery and utilization in clinical trials that are aimed at developing preventative therapies and treatments for PTE. The delayed expression of PTE following TBI presents a window of opportunity within which to intervene, however, there is a need for predictive biomarkers for PTE to understand which populations to enroll in clinical trials. To develop an action plan that will advance the field towards a clinical trial, conference sessions will highlight the most promising advances in PTE research, including potential biomarkers of PTE, as well as examine challenges and solutions to preclinical and clinical PTE research with the objective of understanding gaps in knowledge and opportunities for collaborative steps forward. Additional sessions will discuss the development of an infrastructure for federated data sharing and analysis, as well as hot topics in PTE. Emphasis will be placed on incorporating the experience and needs of those living with PTE as well as the perspective of industry partners. The conference will also highlight the work of early career investigators and provide networking opportunities to catalyze career growth within the field of PTE. As a deliverable, an action plan will be created outlining the next steps to a clinical trial for PTE including input from TBI and epilepsy experts to define these steps. The conference is planned for Milan, Italy, in May of 2024, with an expected attendance of ~150 speakers and participants, diverse in scientific expertise, nationality, gender, and background including representation from underrepresented populations. Scholarships will be provided to enable the attendance of early career investigators, chosen for their scientific promise and diversity of background. With its location in Italy, and partnership linking US-based leading non-profit organization CURE Epilepsy, leading European PTE researchers at the Mario Negri Institute for Pharmacological Research, and International League Against Epilepsy, this conference will bring together a global group of experts and early career investigators to maximize real-world impact on PTE.

Public health relevance
Project Narrative Post-traumatic epilepsy (PTE) is a debilitating recurrent seizure disorder that develops weeks, months, or years after traumatic brain injury (TBI), with no current way to predict who is at risk for its development. The Roadmap from Preclinical Models to Interventional Trials for PTE Conference unites global leading experts in TBI and epilepsy to discuss scientific advances in PTE including promising biomarkers for PTE prediction, and challenges and solutions to clinical and preclinical PTE research problems with the goal of building an actionable plan defining the next steps towards an interventional trial for the development of treatments and preventative therapies for PTE. This conference will highlight the perspective of individuals living with PTE and promote crosstalk between the often-siloed areas of TBI and epilepsy, clinical and preclinical research, and early career and established investigators, encouraging future collaboration and growth of the PTE research field to create impactful solutions for individuals with TBI and PTE.